Mechanisms and Impact of Islet Vascular Inflammation in Diabetes

Insufficient release of insulin from the pancreatic islet β cell is a critical defect in type 2 diabetes (T2D).
Pancreatic islets are highly vascularized, and this vasculature is essential for nutrient supply to islet cells,
insulin delivery to peripheral tissues and as a rich source of signals that support β-cell function. In human T2D
and animal models, islet vasculopathy manifests as endothelial inflammation and capillary dilation and
fragmentation. Moreover, induction of these islet vascular abnormalities in vitro is sufficient to impair insulin
release and/or induce β-cell death.
We have identified human islet amyloid polypeptide (hIAPP) aggregation as a mediator of islet
vasculopathy. hIAPP-derived amyloid deposits accumulate in the extracellular matrix between β cells and islet
capillaries in almost all patients with T2D. We now show that hIAPP aggregation results in islet endothelial cell
cytotoxicity and inflammation, capillary dilation and loss. Using, RNA-Seq we identified Clec14a as a potential
molecular mediator of hIAPP-induced islet endothelial damage. Clec14a is a member of the vascular C-type
lectin family, whose pancreatic expression is restricted to endothelial cells. Clec14a deficiency has been shown
to result in microvascular destabilization, inflammation and cell death in several tissues but has never been
studied in the pancreas. We will now determine if loss of Clec14a exacerbates the islet endothelial response to
hIAPP in vitro and increases susceptibility to hIAPP-induced islet vasculopathy and exacerbates β-cell
dysfunction in vivo.
Capillary-associated pericytes play a critical role in normal microvascular homeostasis. In several tissues,
including islets, pericytes regulate capillary tone and blood flow. Pericyte coverage is also necessary for
endothelial integrity, pericyte-endothelial interactions prevent endothelial inflammation and vessel leakage.
This interaction, in non-islet tissues, is governed both by paracrine signals and cell-cell contact, of which
Clec14a is just one mediator. Disruption of endothelial-pericyte interactions underlies the vascular instability
and inflammation that drives development of diabetic retinopathy and renal fibrosis. Pericyte detachment/loss
also occurs in T2D islets. However, the mechanisms that govern islet endothelial-pericyte attachment, how
these are disrupted in T2D and the consequent impact on β-cell function have not been studied. This proposal
will address this major knowledge gap. Our preliminary data show that hIAPP aggregation leads to islet
pericyte detachment and degeneration. Our data and others’ show this includes a direct toxic effect of hIAPP
on microvascular pericytes, resulting in loss of key signals that govern endothelial cell-pericyte cross-talk. This
proposal will address the hypothesis that disruption of islet endothelial cell-pericyte interactions,
mediated in part by Clec14a deficiency, underlies hIAPP-induced islet vasculopathy and contributes to
β-cell dysfunction. We propose three aims to address this hypothesis:
Aim 1. To determine whether Clec14a deficiency mediates the deleterious vascular effects of aggregated
IAPP in vitro and exacerbates hIAPP-induced islet vasculopathy and β-cell dysfunction in vivo.
Aim 2. To determine the role of islet endothelial cell-pericyte interactions in mediating deleterious effects of
hIAPP aggregation in vitro.
Aim 3. To determine the impact of aggregated hIAPP on islet pericyte function ex vivo and identify islet
endothelial cell/pericyte-derived mediators of impaired insulin release and β-cell death in vitro.
These novel studies will be the first to investigate Clec14a in the pancreas, and to interrogate mechanisms
governing islet endothelial cell-pericyte interactions under normal conditions and following hIAPP aggregation.
This work is significant as it could lead to development of new vascular-targeted therapies which could treat β-
cell dysfunction and may also be relevant for the microvascular disease which affects many tissues in T2D.

Public health relevance
Nearly one in four VA patients is affected by type 2 diabetes, a rate 2.5 times higher than the general US population. T2D is the leading cause of blindness, end-stage renal disease and amputations in the VA population, exerting a significant burden on Veterans as well as the VA health care system. Insufficient release of insulin from the pancreatic islet β cell is a critical defect in the pathogenesis of type 2 diabetes. Recent work has highlighted a key role for the islet vasculature in supporting normal health and function of the islet β cell, while also showing islet vascular pathology in type 2 diabetes. This proposal will investigate novel mechanisms underlying the development of this islet vascular pathology and its effect to impair β-cell function and survival. The findings from this work will also be relevant for the microvascular disease that affects many tissues in T2D. These studies may therefore pave the way for development of new vascular-targeted therapies which could treat multiple aspects of T2D pathology.